Roles of hemocytes and bioactive lipids in the modulation of neuronal excitability and seizure behavior in Drosophila voltage-gated sodium channel mutants

PROJECT SUMMARY
Local and systemic interactions between the nervous system and immune system play important roles in
various physiological and pathological processes. The long-term goal of this project is to obtain a fundamental
understanding of how neuroimmune communications contribute to the regulation of neural development,
physiology, and behavior using an experimental model organism Drosophila melanogaster possessing the
evolutionarily conserved innate immune system. The overall objective in this application is to reveal the roles
and mechanisms of functional interactions between innate immune cells and the central nervous system in the
modulation of neuronal excitability and behavioral hyperactivity in seizure-prone fly voltage-gated sodium (Nav)
channel mutant, paraShu. The project is based on intriguing findings that: 1) paraShu adult seizure severity is
significantly suppressed by diet supplemented with -3 polyunsaturated fatty acids (PUFAs) -linolenic acid
(ALA); 2) hemocyte (macrophage-like blood cell)-specific knockdown of GstS1, a fly ortholog of mammalian
prostaglandin D synthase, mimics the effect of dietary ALA; and 3) both dietary ALA and GstS1 knockdown are
effective during development to suppress seizures in adult mutants. The central hypothesis is that the severity
of adult paraShu is modulated through neural development by the action of innate immune cells in the biological
processes involving bioactive lipid mediators. Two specific aims will be pursued to investigate the hypothesis:
1) Define the roles of hemocytes in modulation of neuronal excitability and behavioral hyperactivity in paraShu
mutants; and 2) Identify genes and signaling pathways involved in hemocyte-dependent modulation of adult
seizures. For the first aim, hemocyte functions will be genetically perturbed and the effects on neural
development, electrophysiological properties, and seizure behavior will be examined in the presence or
absence of phenotypic modifiers using freely moving or tethered behaving adult flies as well as dissociated
primary neuronal cultures prepared from mutant larval brains. For the second aim, a candidate gene approach
will be used to identify genes involved in putative lipid signaling processes, and lipidomics analysis will be
carried out to determine the changes in oxylipins, lipid mediators produced from PUFAs, in the mutants in the
presence or absence of phenotypic modifiers. The proposed multidisciplinary research is expected to reveal
the roles of hemocytes in the diet-dependent modulation of neuronal excitability and behavioral seizures in Nav
channel mutants, and provide novel genetic and molecular insights into the largely unexplored lipid signaling
pathways that play important roles in the modulation of genetically predisposed neurological phenotypes. The
project is scientifically and clinically significant because it will lead to a deeper appreciation of the plastic and
interactive nature of the nervous system controlled by the immune system, and is expected to provide valuable
insights into future strategies to prevent and treat nervous system disorders associated with aberrant immune
function.

Public health relevance
NARRATIVE The main objective of the proposed study is to elucidate the fundamental biological mechanisms by which neural development and function are controlled by dynamic interactions between the nervous system and immune system. This basic science research using the experimental model organism, Drosophila melanogaster, is relevant to public health because the fruit fly possesses the evolutionarily well conserved innate immune system and the expected outcomes are likely to provide valuable information for novel approaches to reduce burden of neurological and psychiatric disorders that are linked to abnormalities in the immune system.